C-Type Lectins and Immune Surveillance in ALD

Project Summary This Administrative Supplement will provide an additional year of mentored research to compensate for research progress and career development that was delayed due to the COVID-19 pandemic. The pandemic forced research labs at the Cleveland Clinic to reduce to a quarter or half capacity for the last year, reduced the number of patients enrolled in studies, and decreased access to many critical lab supplies including reagents. As a result, research focus had to be shifted to remote work, and many year 1 and year 2 research and career goals for the K99 were unmet. During this extra year, the candidate will be able to finish experiments that were put off due to the pandemic and continue to develop skills in clinical immunology, generate the sequencing data outlined in the proposal, and learn leadership skills to transition into independence.